Integrating a Parenting Intervention for Mothers with Opioid Use Disorders into Child Development Services

PROJECT SUMMARY
The number of infants born to mothers with opioid use disorders (OUDs) has more than tripled in the past 15
years and the first year postpartum is an extremely high-risk time for maternal overdose and death. A federal
system of child development programs, called Early Intervention, provides in-home support services to many
families affected by OUDs in the first year of a newborn's life. However, targeted interventions for parents with
OUDs are not a standard element of the services provided. Mothering from the Inside Out is an evidence-
based intervention for parents with substance use disorders proven to decrease the rate of relapse and
improve parent-child interactions. This intervention is currently delivered through addiction treatment centers
by bachelor- and master- level counselors to parents of children over 11 months of age. Yet, clinic-based
mental health services are notoriously difficult for postpartum women to access, adding to the heightened risk
women in recovery face following the birth of a child. I propose harnessing the infrastructure and existing
therapeutic relationships developed by Early Intervention programs to make the evidence-based intervention,
Mothering from the Inside Out, more readily accessible to postpartum women with OUDs. With the support of a
KL2 award, I have taken a community-engaged approach to develop detailed intervention adaptation and
integration strategies for this new setting, called Promoting Caregiver-child Attachment and Recovery through
Early Intervention (pCARE). We are currently in the process of beta-testing the training and deployment of
pCARE with six Early Intervention providers and 10 mothers in recovery from OUDs. This K23 application
details a strategic approach to further refine and test the acceptability and feasibility of pCARE. My research
plan will utilize iterative feedback from a wide group of key stakeholders following the beta-test to refine the
pCARE intervention (Aim 1). We will then assess the feasibility, acceptability, and fidelity of pCARE (Aim 2),
and explore changes in parental functioning (Aim 3) in a pilot feasibility trial with 40 mothers randomized to
receive either pCARE or standard Early Intervention services. My work is guided by the expertise of my
outstanding mentorship team and community partners. With the support of by my mentors, I can achieve my
educational goal to become a behavioral intervention researcher through the following objectives: gain content
expertise in addiction medicine with a focus on pregnant and postpartum women; develop foundational
knowledge of behavioral intervention theory and research; and obtain advanced training in clinical trial design
and statistical methods relevant to prospective clinical trials. At the end of this award, I will have a complete
package including a refined intervention, optimized study procedures, and an understanding of how to further
improve the acceptability and feasibility of pCARE for further testing. I will be positioned to test the intervention
in a fully powered effectiveness trial and begin closing the research-to-practice gap that exists for this
vulnerable population.

Public health relevance
PROJECT NARRATIVE Evidence-based parenting interventions have the potential to help mothers with opioid use disorders cope with the stress of parenting, improve parent-child relationships, and support their recovery, particularly during the postpartum period when the risk for relapse and overdose is exceedingly high. This investigation will refine an adapted evidence-based parenting intervention for delivery to women with opioid use disorders by integrating it into existing home- based child development services. We will test the feasibility and acceptability of the intervention and study procedures in a pilot feasibility trial in an effort to identify novel and scalable approaches to supporting both the mother's recovery and the child's development during this high-risk postpartum time.